The Role of Iron Deficiency in COPD Morbidity

Project Summary
Chronic obstructive pulmonary disease (COPD) affects approximately 10% of adults above the age of 40
and is the third leading cause of mortality worldwide. Comorbid diseases commonly accompany COPD and are
important determinants of COPD outcomes. In addition, exercise capacity and physical activity are strong
independent predictors of all-cause mortality in COPD patients. The two important determinants of exercise
capacity are hemoglobin level, the limiting factor for oxygen carrying capacity, and iron level, which dictates
tissue oxidative capacity. Thus, while iron deficiency and anemia are related, they are distinct conditions with
differing mechanisms of pathophysiology. Currently, compared to anemia, less is known regarding the
association between iron deficiency and COPD morbidity. In limited observational and retrospective clinical
studies, iron deficiency has been shown to be associated with self-reported exacerbations, worse exercise
tolerance, and increased severity of chronic lung disease-associated pulmonary hypertension. Regarding
treatment, there have been proof-of-concept studies showing improvement in exercise capacity with IV iron
repletion in small cohorts of COPD patients. However, given the small scale of the studies thus far, it remains
unknown whether all COPD patients are affected similarly by iron deficiency and whether iron repletion will
provide equal benefit.
The main object of this proposal is to understand the association between iron profile and COPD morbidity
through two novel aims. First, to determine the association between iron profile, specifically ferritin and
transferrin saturation, and COPD-related hospitalization by conducting a retrospective secondary analysis
of a large COPD patient data registry with approximately 85,000 individuals. Second, to prospectively
determine the association between iron profile and 2a) hospital readmission rate and 2b) functional
status by physical activity level, in a cohort of patients recently hospitalized for COPD exacerbations.
The second aim will be nested in an observational cohort study of patients recently hospitalized for COPD
exacerbations that is enriched for exacerbation events. We will obtain iron profiles at 1-week post-index
hospitalization and the cohort will be followed for 12 months with regular interval in-person or telephone
assessments for exacerbations and validated respiratory symptom measures. Physical activity level will be
acquired through step count and heart rate monitoring. This proposal provides an excellent training vehicle for
patient-oriented clinical research through hands on experience following a cohort from enrollment to final
analysis. I will also develop expertise in basic large data management and physical activity data acquisition
and analysis. If we find that iron deficiency is associated with COPD morbidity, future investigation of treatment
with iron repletion and assessment of benefit versus harm would be warranted, and would serve as the
foundation for my future K-level career development award.

Public health relevance
Project Narrative In chronic obstructive pulmonary disease (COPD), the third leading cause of mortality worldwide, comorbid diseases and exercise capacity are known independent predictors of morbidity and mortality. While iron level is an important determinant of exercise capacity and plays a vital role in various biologic processes in the lungs, the association between iron deficiency and COPD morbidity is not well known. This proposal seeks to determine whether iron deficiency, a prevalent and treatable condition, is associated with worse COPD morbidity, specifically hospitalization and functional outcomes.